Summer Research Experience for Veterinary Students

PROJECT SUMMARY
Mississippi State University College of Veterinary Medicine (MSU-CVM) and Tuskegee University College of
Veterinary Medicine (TUCVM) have established a partnership during the previous funding period of this T35
program that has been effective and which both institutions wish to continue. This will be the twentieth year of
T35 funding for MSU-CVM and the fifth year for TUCVM, which had not previously had T35 funding. Our long-
term goal in this T35 is to contribute to the national capacity of veterinarians in biomedical research by
engaging and educating veterinary students in short-term research training early in their curriculum. In the
previous funding period, we utilized the joint collaboration to train 46 and 11 veterinary students at MSU-CVM
and TUCVM, respectively. The immediate goal of this application is to involve veterinary students in short-term
research training opportunities supported by the Ruth L. Kirschstein NRSA Short-Term Institutional Research
Training Grants (T35) program. Again MSU-CVM and TUCVM propose to administer a Summer Research
Experience (SRE) Program to recruit and train veterinary students in biomedical research. Another important
goal of our program is to continue to increase diversity in the veterinary research workforce. Our program will
provide summer research experiences for 12 veterinary students each year that have completed their
freshman, sophomore, or junior year in an AVMA-accredited veterinary curriculum with 9 training positions at
MSU-CVM and 3 training positions at TUCVM. The proposed training will consist of a continuous 12-week
block of time in summer. The program will have three major components: 1) research conducted under the
mentorship of an active faculty researcher, 2) educational activities in research, career development, and
leadership, and 3) training and experience in preparation of scientific presentations. MSU-CVM and TUCVM
will take several steps to ensure the program is jointly operated: both Colleges will participate in selecting
trainees, educational activities will be jointly administered, and trainees will be assigned to MSU-CVM or
TUCVM based on individual research interests. We have operated successfully in this manner in the previous
funding period and propose to continue this collaboration in the next funding period, which this has been
facilitated by outstanding institutional support from both MSU-CVM and TUCVM. Our colleges have unique
research programs to give trainees experience in toxicology, epidemiology, translational research,
genomics/functional genomics, computational biology, infectious disease, oncology, and food safety. One of
the new initiatives we are proposing here are international SRE projects with shared mentorship between
MSU-CVM and African institutions. This will be beneficial for our students and will also enhance diversity in
biomedical research.

Public health relevance
NARRATIVE There is a well-established need (illustrated effectively by the COVID-19 pandemic) for veterinarian-scientists who can investigate the transmission of animal disease microbes to humans. This project will provide veterinary students an opportunity to conduct a meaningful research project and we expect that some of them will pursue additional research training and will contribute to the biomedical research enterprise.